Intracellular immunity, cytosolic DNA sensing by cyclic GAMP synthase, and macrophages in ischemic injury and cardiac remodeling

PROJECT SUMMARY/ABSTRACT
Inhibiting inflammation of the arterial wall by targeting interleukin-1β lowers the incidence of cardiovascular
events. However, we have not discovered strategies limiting inflammation-related injury in acute ischemia. One
major obstacle is the critical gap of knowledge in understanding danger recognition, the actual process that
dictates the scope of inflammation. My long-term goal is to develop immune modulators that modify danger
recognition to contain inflammation-mediated injury after MI. The overall objective of this proposal is to
determine how DNA and its cytosolic receptor the cyclic GAMP synthase (cGAS) propagate injury triggered by
ischemia. The damaged myocardium is enriched with mitochondrial (thousands of copies per cardiomyocyte)
and nuclear DNA. The large amount of DNA poses a serious threat to myocardial repair when macrophages,
the professional phagocytes, detect it and respond with robust inflammatory responses that are originally
intended to get rid of pathogens (from the evolutionary standpoint). The central hypothesis is that recognition of
DNA by cGAS sustains the inflammatory macrophages via activation of the type I interferon (IFN) pathway that
promotes inflammasone activation; as a result, cGAS is crucial in ischemia-induced remodeling. This hypothesis has
been formulated on the preliminary data and the recently published work from my laboratory. The rationale is that
understanding the intracellular danger recognition in ischemic-triggered inflammation has the potential to discover
effective ways of limiting inflammation-related injury. Guided by strong preliminary data, this hypothesis will be tested
by pursuing the following specific aims: 1) Determine whether cGAS activation in macrophages drives ischemia-
induced remodeling and define the source of the cytosolic DNA; 2) Determine whether cGAS sustains
inflammation in macrophages by promoting AIM2 and NLRP3 inflammasome and caspase 11-mediated
pyroptosis; 3) Identify effective and clinically relevant approaches for inhibition of cGAS. Aim 1 will be
addressed using a cGASf/f mouse line to determine macrophage as the responsible cell type. Studies are also
designed to trace the source of the cytosolic DNA. Under the second aim, I will determine if guanylate-binding
proteins (GBP), induced by cGAS activation, increase danger signal visibility to sensors like AIM2 and NLRP3
and if cGAS-depndent priming is essential in cGAS-triggered inflammasome activation in ischemia. Pyroptosis-
mediated by caspase 11 will also be evaluated. Aim 3 will identify clinically relevant strategies to inhibit cGAS
by assessing two agents that treat inflammatory disorders. The study is conceptually novel by targeting DNA
and its receptor cGAS, a bona fide anti-viral response, in the setting of myocardial ischemia. Knowledge
acquired will vertically advance our understanding of the critical role of intracellular immunity in ischemic injury. As
ischemic heart disease is an enormous burden and often a devastating condition, the proposed study moves the field
forward by finding novel strategies alleviating the burden and improve care. Additionally, results will help to understand
potential cardiac side effects from immunotherapy via boosting cGAS-STING pathway activity (in clinical trials).

Public health relevance
PROJECT NARRATIVE Myocardial infarction is the major cause of heart failure that is projected to increase 46% by the year of 2030. My proposed studies aim to understand how macrophages, the key immune cells recruited to carry out tissue repair after ischemic injury, control this crucial process through sensing and responding to DNA presented in the cytosol. My studies will also delineate if two immune modulators that have the potential to disrupt the DNA sensing and responding and are readily available clinically, modulate the behavior of macrophages and promote repair. This research will have the potential to reveal novel therapeutic targets to limit remodeling and heart failure after myocardial infarction.